Investigating the role of the mismatch repair proteins MSH2 and MSH6 in genome stability

PROJECT SUMMARY
Homologous recombination is a critical pathway for repair of DNA lesions, including double-stranded breaks,
ssDNA gaps, and stalled or collapsed replication forks. Of particular importance is the selection of the duplex
template for repair. Recombination between non-allelic repeats instead of the sister chromatid can lead to
genome rearrangements and loss of heterozygosity, both of which have demonstrated significance to an array
of human diseases, particularly cancer. The mismatch repair proteins MSH2 and MSH6 form a heterodimer
that detects base-base mismatches and small insertions/deletions. Not only does it function in postreplicative
mismatch repair, MSH2-MSH6 has also evolved to prevent recombination between mismatched sequences.
Despite the importance of this activity to genome stability, the mechanisms involved remain poorly
characterized. In this proposal, I will use a combination of genetic and genomic approaches to delineate the
mechanism(s) through which MSH2-MSH6 rejects mismatched recombination intermediates and the define the
clinical significance of loss of this important activity in MSH2/6-deficient patient tumors.
In Aim 1A (K99 phase), I will use novel proximity ligation-based assays in the model organism
Saccharomyces cerevisiae in combination with genetic analysis to delineate the mechanism of MSH2-MSH6
rejection of mismatched recombination intermediates. I will examine recombination between an inducible
double-stranded break and each of two templates, one that is perfectly matched, and one that contains ~5%
mismatches. I will determine how MSH2-MSH6 biases recombination towards the perfectly matched template
and identify the effectors that it recruits to achieve this outcome. In Aim 1B (R00 phase), I will transfer the
proximity ligation assays from yeast to human cells and characterize MSH2-MSH6-dependent regulation of
mismatched recombination intermediates in this system. In Aim 2, I will use two different approaches to
systematically characterize the mutational signatures associated with loss of regulation of recombination by
MSH2-MSH6 in MSH2/6-deficient patient tumors as compared to matched healthy tissue controls. In Aim 2A
(K99 phase), I will use unbiased long-read whole-genome sequencing and a genome-wide bioinformatic
approach to identify de novo structural variants in the patient tumor samples. In Aim 2B (R00 phase), I will use
targeted sequencing of long reads containing human lineage-specific LINE-1 elements, which are expected to
be disproportionately involved in recombination-mediated rearrangements as a result of their length and the
high sequence identity of elements within relatively young LINE-1 subfamilies to one another. This work will
provide important insight into the processes that prevent recombination between ectopic repeats and will serve
as the foundation of my research program as I transition to an independent faculty career.

Public health relevance
PROJECT NARRATIVE Mutations in the genes encoding the mismatch repair proteins MSH2 and MSH6 are associated with both germline and spontaneous somatic cancers. MSH2-MSH6 has two distinct functions in genome stability: a well-studied role to correct misincorporation errors made by the replicative polymerases, and an underappreciated role to regulate the homologous recombination DNA repair pathway to prevent genome rearrangements caused by exchange of genetic information between mismatched repeats. This proposal seeks to fill the knowledge gap on the mechanism of regulation of homologous recombination by MSH2 and MSH6 and its clinical significance.